Neurobiology of CNS Injury and Repair

Project Summary
This is a renewal application requesting continued funding for a Neurobiology of CNS Injury and Repair T32
Training Program to support 4 predoctoral fellows per year for a 2-year training period, working toward their
PhD degrees in the fields of traumatic brain injury (TBI), spinal cord injury (SCI), or stroke. The overall goal
continues to be to prepare highly motivated graduate students for careers in neurotrauma research-related
fields by providing broad-based training in the pathophysiology of TBI, SCI, and stroke and the identification of
potential disease-modifying molecular targets that can drive the discovery of pharmacological or gene-based
therapeutic strategies. An Executive Committee will select trainees from a pool of qualified applicants,
generally in their third year of PhD training. Trainees will receive intensive hands-on research mentoring, with
an emphasis on understanding and applying quantitative assessment tools in laboratories of Training Faculty
appointed in the Depts. of Neuroscience, Physiology, Molecular and Cellular Biochemistry, and Pharmaceutical
Sciences who regularly interact and collaborate through their affiliation with the University of Kentucky's (UK)
Spinal Cord & Brain Injury Research Center and Center for Advanced Translational Stroke Science (CATSS).
In addition to coursework, trainees will engage in journal clubs, responsible conduct of research training,
Center and Departmental seminar series, and a customized set of program-wide meetings in Professional
Skills, and Quantitative Literacy-Experimental Design and Statistics (PSQL-EDS). The monthly PSQL-EDS will
facilitate active learning of concepts such as quantitative literacy, statistical analysis, and scientific rigor, as
well as scientific writing and professional development. Of the students appointed to the T32 Program in the
previous 9 years, 13 have completed their PhDs, 2 will complete their PhDs in year 10, and 6 will continue their
PhD training. All those that completed their PhDs continued into science-related positions. Several are
continuing their education (3 postdocs, 1 resident), one is an AAAS science policy fellow at the NIH, and the
majority are pursuing careers in academia (3 Assistant Professors, 1 instructor, 1 researcher) and biomedical
industry (2). The PhD completion and career placement success of the T32 Program is further highlighted by
an outstanding record of recruiting and retaining diverse trainees: a large proportion of appointees are of
underrepresented race or ethnicity, have a disability, or come from disadvantaged backgrounds. The
program's success and continued evolution will be guided by two groups: an Executive Committee comprised
of the Program Directors, Training Faculty, and senior UK faculty who bring expertise in administration,
mentoring, and inclusion research initiatives, and an External Advisory Board of national leaders in TBI, SCI,
and stroke research. Through the pairing of comprehensive, research-intensive training with didactic and
interactive educational/career development activities delivered from diverse perspectives, this T32 Program is
uniquely positioned to fill a growing need for rigorously trained scientists who desire careers in neurotrauma.

Public health relevance
Project Narrative Acute central nervous system (CNS) injuries such as spinal cord injury, traumatic brain injury, and stroke share many common cellular and molecular mechanisms of damage and repair. These mechanisms often differ substantially from other genetic, developmental, or degenerative brain diseases, necessitating specialized education and research training for those who pursue careers in CNS injury research with the goal of lessening the health-related burden of CNS injury on survivors. The Neurobiology of CNS Injury and Repair T32 Program is designed to provide outstanding, comprehensive educational and research-intensive training to predoctoral students and fully prepare them for their transition to independent careers.